Genome Editing Treatment for Catecholaminergic Polymorphic Ventricular Tachycardia

There is a fundamental gap in treatment for Catecholaminergic Polymorphic Ventricular Tachycardia (CPVT).
Pharmacological treatment of CPVT is partially effective for a disease that causes sudden death. A fuller
understanding of novel gene editing approaches is needed to develop safe, non-surgical, and effective
therapies that target the underlying causes of CPVT. In approximately 60% of CPVT patients, mutations in
RYR2 cause arrhythmia through abnormal calcium handling in cardiomyocytes. The lab has shown that using
CRISPR/Cas9 to knockdown the RYR2 mutant allele is effective in preventing ventricular tachycardia(VT) by
decreasing expression of dysfunctional RyR2. The overall objective of this application is to improve therapy for
patients with CPVT. Preliminary data generated by the applicant showed that directly targeting a disease-
causing mutation with traditional CRISPR/Cas9 therapy in a CPVT mouse model prevented pacing induced VT
but reduced total expression of RyR2. The central hypothesis of this proposal is that novel methods of
CRISPR/Cas9 gene editing can treat CPVT by specifically correcting causative mutation sites, reducing mutant
RyR2 expression while preserving total RyR2 expression, normalizing Ca2+ handling, and decreasing
susceptibility to VT. The rationale for this research is that an understanding of the effectiveness and specificity
of gene editing in the correcting mutations in the heart may lead to safe novel approaches to treat genetic
cardiac disorders. The hypothesis will be tested with the following specific aims 1) test the therapeutic potential
of human RYR2 mutation correction in an iPSC-CM preclinical model of CPVT and 2) test the therapeutic
potential of mouse RYR2 mutation correction in a mouse model of CPVT. To determine aim 1, we deliver
CRISPR/Cas9 prime editing vectors to IPSC, derive CM, and measure function through confocal and light
sheet imaging of IPSC and 3D cardiac organoids. To determine aim 2, we will use Lenti-CRISPR/Cas9 prime
editing vectors to treat mouse models of CPVT and measure long-term cardiac function through
echocardiography, EKG, programmed electrical stimulation, and molecular analysis. This research is
significant in that it will advance gene editing correction of RYR2 mutations as a safe and effective method for
the treatment of CPVT.

Public health relevance
Project Narrative The proposed research project is relevant to public health as acquiring knowledge regarding genome editing of cardiac Ryanodine Receptor Type-2 is expected to lead to a better understanding of how cardiac gene therapy can treat ventricular arrhythmias and other cardiovascular conditions related to dysregulation of this critical calcium channel. Such knowledge may ultimately lead to new therapeutic approaches that focus on correcting the underlying causes of genetic cardiac disorders. Thus, this research is relevant to the NIH’s mission as it seeks to acquire knowledge that will aid in the treatment of human disease and disability.